Statistical Training to Enhance the Excellence of Research (STEER) in Biomedical Sciences

Summary
Large-scale biological studies along with routine use of digital sensors and mobile devices to collect medical
data have created a data deluge, imposing new challenges on scientists and practitioners to process and
analyze a large amount of data for information extraction, discovery, and decision making. Tackling these
emerging challenges requires interdisciplinary teams of scientists with complementary domain knowledge and
analytical skills, who can work together effectively toward the common goal of understanding complex biological
phenomena and improving treatment effectiveness. To develop such a framework for sustainable support of
collaborative environments at the intersection of biomedical sciences and biostatistics, we propose to create an
integrative, interdisciplinary, and interactive training program called Statistical Training to Enhance the Excellence
of Research (STEER) in Biomedical Sciences. At its core, STEER provides PhD students with the required
training on statistical thinking for biomedical data analysis. We will also prepare our trainees with the required
skills to handle big data problems and the associated computational challenges, given that the emerging
biomedical studies have become increasingly data-intensive. Additionally, we will introduce trainees to state-
of-the-art statistical machine learning techniques and their role in biomedical research.
Our program's overall goal is to teach students the underlying principles of statistical analysis so they can
solve real-world biomedical problems. STEER will foster a stimulating environment for training and mentoring
the next generation of biomedical scientists with proper exposure to modern developments in biostatistics,
and biostatisticians with expertise in solving complex and data-intensive problems for fundamental research in
biomedical sciences. To this end, our research training program's main objectives are as follows:
Obj 1: Use the science of team science to create a stimulating collaborative environment at the interface of
biomedical sciences and biostatistics;
Obj 2: Develop an interdisciplinary education framework to cultivate an exceptional learning environment for
training a new generation of scientists with a deep understanding of modern biostatistical techniques and
complex biomedical systems;
Obj 3: Create a collaborative research framework where our trainees learn to develop innovative data
analysis methods that are fundamentally sound, methodologically robust, and computationally feasible for
investigating biomedical problems;
Obj 4: Provide professional development training and organize career planning activities to prepare our students
for a variety of academic and nonacademic career options, while ensuring a high level of PhD completion
rate and appropriate time to degree.

Public health relevance
Narrative Our program will create an interdisciplinary education framework to cultivate an exceptional learning environment for training a diverse generation of scientists with deep command of biostatistical methods and their applications in biomedical sciences. In this environment, biostatistics trainees will develop novel data analysis methods inspired by challenging biomedical problems, and biomedical trainees will explore new approaches for solving their scientiﬁc problems using advanced biostatistical methods. We expect this bilateral research training program to contribute to the advancement of science both in terms of methodological developments and solving real-world problems.